Translation Initiation Inhibitor for Cancer Therapy

PROJECT SUMMARY
The overall goal of this project is to expand our understanding of the cellular and molecular mechanisms that
link translation initiation inhibition to apoptosis and tumor suppression triggered by Interleukin-24 (IL-24).
Clinical testing of IL-24 as a gene-based therapeutic for the treatment of solid tumors demonstrated that IL-24
is efficacious and is safe. This proposal is consistent with the current view that modern anti-cancer therapy
must be target-specific, inhibit the growth of cancer with minimal effect on normal cells, and that effective anti-
cancer agents of low toxicity can be achieved by targeting the fundamental mechanisms responsible for the
genesis, maintenance, and/or progression of cancer. We have shown that IL-24 inhibits translation initiation by
inducing phosphorylation of eukaryotic initiation factor 2 alpha (eIF2a), depletion of the ternary complex,
upregulation of expression and activity of ATF4, and inhibition of eIF4F complex in vitro. The working
hypothesis of this application is that restoration of physiological restrains on translation initiation by
Interleukin 24 (IL-24), an inhibitor of translation initiation, represents a new paradigm in cancer
therapy. We have conducted pharmacokinetic, toxicity, and in vivo efficacy studies on IL-24, which established
not only its anti-cancer activity, but also that IL-24 translationally down-regulates the expression of PD-L1, a
critical anti-tumor immunity factor. In this application we propose to continue our efforts to characterize the
cancer cell-specific actions of IL-24 as an inhibitor of translation initiation. Specifically, we will 1) test IL-24 anti-
cancer translation initiation inhibition-mediated mechanism of action in vivo (Specific Aim 1), 2) determine the
role of activating transcription factor 4 (ATF4) on IL-24-mediated inhibition of translation initiation and
apoptosis, (Specific Aim 2), and 3) investigate for the first time the role of PD-L1 down-regulation in the anti-
cancer effect of IL-24 and its potential utility as an immune checkpoint inhibitor (Specific Aim 3). For these
proposed studies, we will collaborate with Dr. Bertal H. Aktas, from Harvard Medical School, and expert on
targeting translation initiation for cancer therapy and Dr. Juan Lafaille, from New York University School of
Medicine, and Immunology expert.

Public health relevance
PROJECT NARRATIVE Cancer ranks as the second leading cause of death in men and women of all age groups in the U.S., and currently 1 out of 4 death in the U.S. is due to cancer. The severe adverse effects due to many anti-cancer therapeutic strategies currently in use are associated with their undesired effects on healthy, non-cancer cells. This project, therefore, is directed toward understanding cellular and molecular mechanisms that will help develop a specific cancer therapy that only kills tumor cells.